Shared and differential vulnerabilities of stress and reward processing in psychosis-risk syndromes or early-stage depression

Abstract
The clinical high-risk (CHR) or “prodromal” framework has provided a platform for tracking the onset of psychosis
and identifying the neurodevelopmental mechanisms of risk for this disorder. It is now well established, however,
that affective symptoms in CHR samples are essentially universal, persist longitudinally, and contribute to
disability regardless of psychosis transition. Given the substantial neurobiological proximity of psychotic and
affective disorders, the extent to which current biomarkers in CHR reflect risk for psychosis, common affective
illness, or both remains largely unknown. Broadening the scope of detection to the early affective stages has
potential to strengthen pathogenic models of psychosis by highlighting shared and unique vulnerability
mechanisms while informing treatments that are relevant to a wider range of individuals. This study will identify
shared and differential impairments of stress and reward processing among youth with psychosis-risk syndromes
or early-stage depression (ESD). In a task-based fMRI design, youth with CHR, ESD, or no psychopathology
will complete a probabilistic reinforcement learning paradigm before and after an acute stress manipulation.
Using an established computational model we will generate estimates of theoretically relevant learning
parameters, compare them across groups, and relate them to neural and hormonal data. We hypothesize that
the striatum represents a shared locus of reward-based dysfunction across the early and high-risk stages of
psychosis and depression, but risk-specific differences may lie within the prefrontal cortex. The results of this
study will represent a significant step forward in our transdiagnostic understanding of emerging psychopathology,
with implications for both generalizable and personalized intervention. By the end of the project period I will have
established expertise in task-based fMRI research, independence in computational modeling of behavior, and
expert knowledge of the interplay between stress, reward, and neurodevelopment across mood and psychotic
disorders. Together this will provide a unique combination of clinical and methodological expertise and prepare
me for my long-term goal of improving preventative intervention through longitudinal research.

Public health relevance
Project Narrative Prediction and prevention of psychosis is an international priority given the tremendous personal and public health burden associated with the illness. Progress in this initiative has been hindered by a poor mechanistic understanding of risk and by the siloed nature of research on the high-risk stages of psychosis versus related disorders such as depression. To inform generalizable prediction and prevention, this proposal will identify shared and differential vulnerabilities of two neurobehavioral dimensions with known relevance to psychotic and depressive illness – stress and reward processing – among youth with emerging manifestations of these disorders.